NRSA Training Core

This TL1 application responds to a critical need to train predoctoral students and postdoctoral fellows in skills, methods, and competencies of clinical and translational research and to provide mentored research experiences. The TL1 training program within OCTRI is distinguished by a strong pool of trainees who represent the full range of translation and disciplines, an emphasis on team science that is at the core of all activities, and individual development of the competencies of clinical and translational research.
Both predoctoral and postdoctoral trainees are included in this application. The program described herein is complex, as it includes all axes of translation (T1 through T3/T4), clinical and basic science scientists (MD, DMD, PharmD, and PhD), a broad range of disciplines, as well as four universities (OHSU, University of Oregon, Oregon State University, and Portland State University) and their mentors, students, and postdoctoral trainees. Graduate and professional students create an individualized training specific to their career plans, as well as to their proposed research. MD students will enroll in the Master of Clinical Research program and complete all requirements for the degree within the training period, including a mentored research project. Graduate students must complete competencies in quantitative methods, data management, and research leadership. Postgraduate trainees complete a similar plan, focused on an individualized plan for career development.
TL1 trainees will be trained in science communication and writing. Transdisciplinary training will be enhanced by a clinical and translational science journal club and participation in translational research rounds for non-clinicians. Students will embrace the value of team science through formation of inter-institutional mentorship teams and through participation in common activities, such as the journal club.
This program will create clinicians and scientists who will pursue careers in transdisciplinary clinical and translational science.